TOPICAL CLOTRIMAZOLE IN THE TREATMENT OF AIDS ASSOCIATED KAPOSI'S SARCOMA

To evaluate the efficacy of topical treatment of cutaneous Kaposi's sarcoma lesions with clotrimazole administered as a 1% cream.